Multiplex Ultrasound Imaging for the Detection of Head and Neck Lymph Node Micrometastases

Project Summary
Determining whether a tumor has spread to the regional lymph nodes is critical for staging and treatment planning
for several types of cancer, including cancers of the head and neck. This determination is routinely performed
through a sentinel lymph node biopsy procedure. While widely accepted and proven to be effective, the sentinel
lymph node biopsy procedure suffers from some shortcomings. It is an invasive surgical procedure that can lead
to adverse events and metastases smaller than 2 mm routinely go undetected. These small metastases have
been shown to have implications in the progression of the disease. Thus, patients who undergo the sentinel
lymph node biopsy may receive a suboptimal treatment plan. In this project, we will develop a noninvasive
ultrasound-based molecular imaging tool to identify micrometastases in the lymphatics. We will develop
perfluorocarbon nanodroplet contrast agents targeted to cell surface receptors via directional conjugation of
antibodies. We will synthesize two classes of nanodroplets, each with a different boiling point and molecular
target. One nanodroplet formulation will be targeted to the epidermal growth factor receptor (EGFR) to enable
molecular detection of cancer cells, while the other will be untargeted to act as a delivery control. Based on the
phase-change behavior visualized in ultrasound images, we will differentiate between the EGFR-targeted
nanodroplets and the nonspecific control. Then, we will apply ratiometric and kinetic modeling strategies to use
the different accumulation patterns to highlight regions with small metastases. The nanodroplets and imaging
methods will be tested in polyacrylamide phantoms before the dual tracer design is applied to a small animal
model of head and neck cancer metastasis. The overall result will be a method that can detect small pockets of
metastases in the lymphatics several centimeters deep in tissue.

Public health relevance
Project Narrative Head and neck tumors typically metastasize to lymph nodes at early stages of the spread of the disease. A new method to detect the presence of a small number of cancer cells in the lymph nodes could help physicians choose a more effective treatment strategy and ultimately improve survival rates.